4/8: INIA Stress and Chronic Alcohol Interactions: Role of corticotropin-releasing factor in cortico- and thalamo-striatal pathways in regulating alcohol-stress interactions

PROJECT SUMMARY
Alcohol use disorder (AUD) is a devastating neuropsychiatric condition that is characterized by chronic and
relapsing episodes of excessive, uncontrolled alcohol consumption. AUD is also associated with significant
disruption of brain function and behavior, frequently presenting with cognitive deficits and comorbid negative
affective disorders (e.g., anxiety and depression). These negative affective and cognitive disturbances that are
present during abstinence from alcohol drinking can drive relapse-like behaviors in both humans and rodent
models and are often exacerbated by stress. Thus, alcohol and stress may be working synergistically to cause
more profound cognitive deficits that lead to decreased cognitive control over alcohol consumption, but the
molecular and cellular adaptations and the neurocircuitry underlying these concerted changes are not well
understood. The ventral striatum, specifically the nucleus accumbens (NAc), mediates aspects of alcohol taking
and seeking, negative affect, and is one of the primary outputs of both the medial prefrontal cortex (mPFC) and
the anterior paraventricular thalamus (aPVT). These circuits mediate appetitive and reward-motivated behaviors,
are sensitive to stress and alcohol, and are involved decision making and choice behaviors particularly during
motivational conflict. Additionally, in both the mPFC and aPVT, pro-stress molecules, like corticotropin-releasing
factor (CRF), are recruited and have been implicated in regulating responses to stress and/or alcohol. Thus, this
component of the INIAstress Consortium seeks to understand the mechanisms and circuitry involved in the
complex interaction between stress and alcohol exposure that engender such high rates of alcohol consumption,
cognitive impairments, and negative affective states. We provide evidence that the chronic intermittent ethanol
(CIE) exposure model and repeated forced swim stress (FSS) alter reward-choice behaviors under conditions of
motivational conflict. We also show that mPFC CRF knockout blocks the escalation of alcohol drinking in the
CIE-FSS model. The overarching hypothesis is that CIE-FSS hyper-recruits CRF in the mPFC and aPVT to
promote excessive drinking, cognitive deficits, and anxiety-like phenotypes. In Aim 1, we will identify chronic
alcohol- and stress-induced changes in synaptic and functional plasticity that occur in a CRF-dependent and
independent manner in mPFC®NAc and aPVT®NAc circuitry. Studies in Aim 2 will focus on understanding the
influence of CRF on mPFC function and circuitry using high-density silicon Neuropixels probes and fiber
photometry. Finally, Aim 3 will identify the role of CRF in the aPVT and its influence on aPVT®NAc projections
in the CIE-FSS model. The focus of this new INIAstress Consortium component is to understand the broader
implications of CRF modulation of neurocircuitry regulating reward-guided behaviors in chronically stressed,
alcohol dependent mice, which is critical to our understanding of the complex interaction between alcohol and
stress, and aid in identifying promising therapeutic targets.

Public health relevance
PROJECT NARRATIVE Relapse to alcohol use in dependent individuals is exacerbated by stress and the experiments outlined in this proposal will help inform our understanding of the neurobiological mechanisms that underly the complex relationship between alcohol use disorder (AUD) and exposure to stress. Ultimately, the data collected from these studies will provide valuable information about mechanisms that contribute to uncontrolled alcohol use, cognitive dysfunction and anxiety-like behaviors characteristic of AUD, and will help to identify new pharmacotherapeutic targets for the treatment of AUD, especially in the context of chronic stress.